Deciphering the Functional Role of PPP2R1A Mutations in Cancer

Project Summary
The adoption of next-generation sequencing (NGS) for patient tumor samples has transformed the approach to
cancer treatment by clinicians and researchers in the past five years. Most mutations identified through
sequencing in cancer are genes mutated across a wide range of cancers or in a specific cancer type. One gene
mutated primarily in high grade gynecological malignancies is PPP2R1A, which encodes the alpha isoform of
the A subunit (A⍺) of Protein Phosphatase 2A (PP2A), an established tumor suppressor. PP2A is a family of
Serine/Threonine phosphatases composed of a C (Catalytic) subunit, which binds an A (Scaffolding) subunit
allowing for one of 20 distinct B (Regulatory) subunits to bind. Depending on the B subunit bound, there can be
over 60 different PP2A heterotrimeric holoenzymes active in the cell at any time. PP2A inactivation occurs
through nongenetic and genetic mechanisms in human cancer. In cancer, the most mutated subunit of PP2A is
A⍺. Interestingly, missense mutations in this subunit are highly enriched in select tumor types, specifically high-
grade endometrial cancers. Hotspot mutations in this subunit are enriched in two domains, known as HEAT 5
and HEAT 7. These mutations bias heterotrimer formation by attenuating tumor suppressive PP2A B subunit
binding, resulting in tumorigenesis. Our group identified a series of small molecule PP2A Molecular Glues
(PMGs) that restore tumor suppressive B subunit binding to mutant A scaffolds and drive significant tumor
growth inhibition and regressions in vivo. However, many cancer-associated mutations lie outside these hotspot
regions. While hotspot mutations represent approximately 30% of identified mutations in A⍺, 70% of all the
identified mutations remain uncharacterized. There are multiple ways to evaluate gene/protein function using
cell-based assays. One such approach is Deep Mutational Scanning (DMS), which simultaneously assesses the
impact of multiple gene variants. Therefore, I hypothesize there are uncharacterized mutations that 1) drive
tumorigenesis and 2) will impact response to drugs targeting PP2A (PMGs). Based on this hypothesis and our
preliminary data, I propose to use DMS to characterize the function of all possible A⍺ mutations and combine
DMS with targeted based approaches to determine the effects of A⍺ mutations on therapeutic response to PMGs.
Experiments in Aim 1 will profile a functional assessment of every possible missense variant of A⍺ to determine
their pathogenicity. Aim 2 will use our generated HEAT 5/7 libraries as well as the top 10 recurrent A mutations
under the selective pressure of PMG treatment to determine which mutations will be responsive or resistant.
This is important information for the lead PMG in this series as it is planned to undergo clinical trials in 2025.
Combined, this data will provide a comprehensive understanding of the mutational landscape regulating PP2A
function and activity as well as serve as a resource for many researchers in and outside our field (Aim 1), while
providing critical inclusion and exclusion criteria in the design of the first clinical trials for the lead PMG (Aim 2).

Public health relevance
Project Narrative Missense mutations in PPP2R1A, the A⍺ subunit of PP2A, occur in a wide range of human cancers with hotspot mutations which drive tumor development and progression. However, most of the cancer-associated mutations identified in the PPP2R1A gene have yet to be functionally classified as pathogenic or tolerated. This project aims to develop an unbiased systematic profiling approach to begin to functionally classify these variants of unknown significance and identify PPP2R1A mutations sensitive or resistant to PP2A molecular glue (PMG) treatment as a potential therapeutic avenue for patients.